Predicting the multi-omic impact of psychiatric GWAS associations

PROJECT SUMMARY / ABSTRACT
Our understanding of schizophrenia (SCZ), bipolar disorder (BPD) and anorexia nervosa (AN) is
advancing rapidly. We have identified polymorphisms and genes associated with all three disorders, although
AN is still understudied compared to SCZ and BPD. As sample sizes for genome-wide association studies
increase, larger numbers of associated variants will surely be identified, particularly for AN, which is projected to
increase to 50,000 cases from ~3,500 currently, by 2019. However, such studies provide, at best, long lists
of associated loci, which are not easily biologically interpretable. Consequently, we do not yet understand
the key biological mechanisms underlying these diseases, and few effective treatments or medications are
available. Methods that provide insight into the associations from these studies will be vital to furthering our
understanding of disease etiology, and will have substantial public health impacts.
We propose to develop statistical models to translate existing associations from these studies into
biologically relevant information. These models are an innovative approach that capitalize on existing
successful genetic studies. We use large, publicly available ‘multi-omic’ datasets with proven relevance to
SCZ, BPD, and AN (for example brain gene expression, cell-type specific histone modifications, and gut
microbiota) to build powerful multi-omic predictors. These may be used to predict higher-level measures (for
example gene expression) from genotype, and test for association with disease. These types of associations
may lead to increased understanding of underlying biological mechanisms, and opportunities for
development of medications and therapeutic interventions.
In specific aim 1, we will update and improve on our existing brain gene expression prediction models,
using a large collection of post-mortem brain samples from the dorso-lateral pre-frontal cortex and anterior
cingulate cortex. These samples will allow us to build large, well-powered, highly accurate prediction models.
We will apply these models to existing studies of SCZ, BPD, and AN to provide disease-associated genes.
In specific aim 2, we will extend our approach to include prediction of developmental brain gene
expression, and again will apply our models to studies of SCZ, BPD, and AN. These analyses will provide
trajectories of gene expression throughout development, and will identify genes associated with SCZ, BPD
and AN at distinct developmental stages.
In specific aim 3, we will create models predicting cell-type specific histone modifications and gut
microbial composition from genotype, and will apply these to studies of SCZ, BPD, and AN. These analyses
will elucidate the role of specific histone modifications (H3K4me3 and H3K27ac), in neurons and non-neurons,
as well as the role of microbial diversity and specific bacterial species, in SCZ, BPD, and AN.

Public health relevance
PROJECT NARRATIVE Genome-wide association studies (GWAS) have been instrumental in understanding the genetic underpinnings of complex traits such as psychiatric disorders. In this project, we will develop and apply algorithms to translate these findings into more biologically interpretable measures; our methods will allow quick and easy prediction of multi-omic data from GWAS, bypassing the need for tissue or sample collection, and allowing psychiatric multi-omics to be studied for the first time at the necessary scale. Our results will highlight putatively causal biological mechanisms for a range of psychiatric disease including schizophrenia, bipolar disorder, and anorexia nervosa.